Administrative Supplement: Extracellular non-coding RNA biomarkers of hepatocellular cancer

DESCRIPTION (provided by applicant): The overall goal of this application is to identify and qualify exosomal non-coding RNA based biomarkers in the circulation to detect early stage disease in patients at risk, to predict recurrence after surgery and to monitor response to therapy in patients with hepatocellular cancer (HCC). The incidence of this cancer is increasing and survival remains poor. Early detection of HCC is essential to survival, yet current biomarkers such as AFP lack the sensitivity to sufficiently detect early stage cancer amenable to surgical cure. Our preliminary studies have identified several microRNA and long-non-coding RNA that are selectively enriched within exosomes released from HCC cells. Moreover, we have cloned a novel long non-coding RNA gene, TUC339 that is very highly enriched in exosomes released from HCC cells, and that can be detected in serum from patients with HCC. We hypothesize that tumor specific non-coding RNA that are selectively released within exosomes into the circulation can be detected to provide highly specific biomarkers for HCC. This project will test this hypothesis using a rigorous two phase biomarker development process to evaluate the utility of exosomal TUC339 and to identify other extracellular non-coding RNA (exRNA) as diagnostic and prognostic biomarkers of HCC. The goal of the first phase will be to identify lead candidates and to develop digital PCR based assays for their detection whereas the goals of the second phase will be to validate the clinical utility of promising exRNA candidates by prospectively validating their capability for diagnosis and as biomarkers of recurrence or treatment response. The study design includes (a) evaluation of identified exRNA candidates and further discovery studies for known or novel long non-coding RNA, (b) explicit biospecimen collection and processing, (c) a multi-stage integrated approach with a prospective case control study, comparison with independently obtained case-control reference samples, and an independent multi-center validation study either as part of a planned on-going study (HEDS) or through a new consortium-based study. Additionally, we will prospectively evaluate exRNA as predictors of recurrence or treatment response. Through these efforts, we expect to develop novel analytical assays for circulating exRNA and to identify a clinically relevant biomarker that will be useful as a diagnostic, prognostic or treatment response marker for patients with HCC.

Public health relevance
PUBLIC HEALTH RELEVANCE: A goal of this project is to identify new RNA markers circulating within exosomes for early diagnosis and improved care of liver cancer, and thereby to improve the care and outcomes from liver diseases. These studies will identify new non-coding RNA that will be clinically useful disease biomarkers, as well as develop novel sensitive assays for their detection. The results will have a broader impact by increasing basic knowledge about non-coding RNA and their detection and use as biomarkers for other diseases. __SpecificAimsTextDelimiter__ Extracellular non-coding RNA biomarkers of hepatocellular cancer The incidence of Hepatocellular Carcinoma (HCC) has been increasing in the United States, and the survival from this cancer remains poor. Early detection of HCC is essential to survival, yet current methods of detection using blood based biomarkers such as alpha-fetoprotein (AFP), Des- gamma-carboxy-prothrombin (DCP) and AFP-L3 lack the sensitivity to sufficiently detect early stage cancer amenable to surgical cure. Cirrhosis is the most important risk factor for patients to develop HCC. Although clinical practice guidelines recommend surveillance of HCC in patients with cirrhosis, the currently used tumor marker AFP has poor performance. Most patients with HCC are diagnosed at an advanced stage when curative surgical intervention such as liver resection or transplantation cannot be performed. Therefore, there is an urgent need for novel markers that can lead to the early diagnosis of HCC. A blood based test that could replace or complement AFP for the surveillance of high-risk patients to detect early HCC or monitor response to therapy would have a major impact on management and outcomes of patients with advanced liver disease and HCC. Deregulated expression of non-coding RNA (ncRNA) occurs in HCC. The overall goal of this proposal is to identify and qualify circulating ncRNA based biomarkers in order to detect early stage HCC in patients at risk, and to monitor response to therapy. We have identified that HCC cells can release vesicles, exosomes, with selectively enriched content of ncRNA. In profiling studies of ncRNA expression from HCC cells and exosomes derived from these cells, we identified several microRNA and long-non-coding RNA that are selectively enriched within exosomes. Moreover, we have identified and cloned a novel ultraconserved long ncRNA gene, TUC339 that is very highly enriched in exosomes released from HCC cells, and that can be detected in serum from patients with HCC but not in controls. We hypothesize that tumor specific ncRNA that are selectively released within exosomes into the circulation will remain stable and provide highly specific biomarkers for HCC. To test this hypothesis, we propose a two phase biomarker development approach to evaluate the utility of exosomal TUC339 and other extracellular ncRNA (exRNA) as diagnostic and prognostic biomarkers of HCC. The goal of the first phase will be to identify and develop assays for exRNA candidates with potential for further study as biomarkers for HCC whereas the goals of the second phase will be to validate the clinical utility of promising exRNA candidates identified from the first phase. We propose the following specific aims: Phase I Aim 1: To identify and select a panel of exRNA biomarker lead candidates associated with HCC. Aim 2: To develop and validate blood based assays for TUC339 and other circulating exRNA candidate biomarkers and to identify the top 3 candidates. Phase II Aim 3: To conduct a prospective case-control study with which to evaluate the diagnostic utility of the top 3 candidate exRNA as biomarkers of HCC and to identify the primary candidate for further study. Aim 4: To assess the utility of exRNA biomarkers in (a) predicting recurrence of HCC following transplantation or resection and (b) as a marker of response to therapy. Aim 5: To validate the utility of the primary exRNA biomarker for early detection of HCC using two existing available biorepositories. Aim 6: To validate the utility of the primary exRNA biomarker for diagnosis of HCC in patients with cirrhosis in a prospective case-control study using either (a) an on-going National Cancer Institute Early Detection Research Network study (HEDS), or (b) a new multi-center consortium. Similar to the high failure rate for most drugs during development, many biomarker studies have not yielded promising results. To increase the chances for success and to obtain clearly defined results for each step of the process, we have proposed a rigorous biomarker development process. The study design includes (a) evaluation of identified exRNA candidates and further discovery studies, (b) explicit biospecimen collection and processing, (c) a multi-stage integrated approach with a prospective case control study, assessment in independent reference cohorts using banked samples, and an independent validation study as part of an on-going study (HEDS) or through a new consortium-based study. Additionally, we would evaluate exRNA as predictors of recurrence or treatment response. Through these efforts, we expect to develop a reliable, well-defined and clinically relevant biomarker based on detection of exRNA that will be useful as a diagnostic, prognostic or treatment response marker for patients with HCC.